ANIMAL MODELS OF NEUROPSYCHIATRIC DISORDERS

1) Our hamster separation model of depression was tested for changes in corticotropin releasing factor, ACTH and cortisol. 2) Mice treated chronically with steroids were tested for hyperactivity of their central dopamine pathways, both behaviorally and biochemically, as a model for steroid-induced psychoses. 3) The central hypothalamic binding site for anorectic drugs such as amphetamine was analyzed for its role in regulation of feeding behaviors. 4) A benzodiazepine which antagonizes the biochemical actions of ethanol in rat brain was found to prevent and reverse ethanol-induced intoxication in rats. 5) Behavioral analysis of rats treated chronically with interleukin-II revealed reductions in exploratory and social behaviors at doses of IL-II analogous to those which induce psychoses when used to treat cancer patients.